Older Adult Social Participation, Gender, and Cognitive Decline

PROJECT SUMMARY/ABSTRACT
Identifying ways to delay or prevent cognitive decline and dementia remains a priority of the NIA. As part of this
work, there is growing recognition that social participation and community connectedness may reduce the risk
of these diseases. Unfortunately, this research has provided little specificity into how various social activities
may differentially predict cognitive decline. There has also been little inquiry into how older adult social
participation or its relationship with cognition might differ by gender.
Unlike many standard survey items (e.g., health, education), there is insufficient consistency with how social
participation is measured in social surveys and utilized in empirical research. In particular, the use of social
participation “summary measures” (a) may obscure differential associations between cognition and underlying
social activities, and (b) often include items that are, arguably, not “social participation” (e.g., meeting with
family members). This has resulted in two limitations: One, it is not known which social activities—and to what
extent these activities—are driving any associations. Two, it is difficult to compare results among similar
studies, raising concerns about validity and reliability.
This project has three aims. One, we will investigate how associations between social participation and older
adult cognitive functioning differ by social activity. Two, we will identify mechanisms that link particular social
activities to cognitive health. Three, we will investigate to what extent associations between social participation
and older adult cognitive functioning differ by gender. To accomplish these goals, we will utilize four large
nationally representative longitudinal studies of older adults.
Dr. Eric Vogelsang, PI, has an established publication record of older adult social participation and health
research. The collaborators on this project have extensive experience in cognitive functioning research,
mentoring, and NIH grants. Working at a “Super” Hispanic Serving Institution (CSU-San Bernardino), the
project will provide research experience to students with limited opportunities.
The proposed study will produce three benefits. One, it will inform patients, practitioners, and policy makers
looking to delay or prevent the onset of cognitive decline. Two, it will bring recognition to the health implications
of gender inequality in older adult social activity. Three, we expect this work to motivate standardization of
“social participation” measures in social surveys.

Public health relevance
NARRATIVE Magnified by population aging, researchers continue to search for ways to protect against cognitive decline or Alzheimer’s dementia in older ages. This study will determine to what extent particular social activities are associated with cognitive change, and how these associations differ by gender. Findings may lead to informed gender-specific activity recommendations and an eventual standardization of social participation measures in social surveys.